Occupational Safety and Health ERC, University of Illinois at Chicago

[unreadable] Training Programs Director [unreadable] Office of Extramural Programs [unreadable] NIOSH/CDC [unreadable] Cincinnati, OH 45226 [unreadable] [unreadable] [unreadable]